Neuroscience Undergraduate Research Experiences (NURE): Utilizing community partners to build specialized and enhanced neuroscience research programs for undergraduates

PROJECT SUMMARY
In the last decade, due to Congressional budget cuts, NIH funding for biomedical research has plummeted
despite a growing public health need. Beyond the obvious effect of this reduction on the productivity of research
labs, this funding climate likely dissuades undergraduate students from pursuing careers in biomedical research.
This effect will be particularly deleterious to the study and understanding of chronic neurologic disease, an area
of growing concern. We aim to counteract this possibility by supporting specialized summer undergraduate
research experiences neurodegenerative disease. The rationale for this proposal is that by strengthening
undergraduate research programs in neurologic disease, we can begin to build a pipeline of skilled researchers
to respond to increasing rates of neurodegenerative diseases as our population ages. This proposal aims to
continue to implement and grow a biomedical research program. This new program, the Neuroscience
Undergraduate Research Experience (NURE), is a cross-disciplinary and community-engaged biomedical
summer undergraduate research program. The objective of the NURE summer program is to increase student
understanding of and exposure to the underlying science of pain and neurological disorders, and importantly, to
offer a more complete and authentic experience, by bridging basic science research with an understanding of
clinical and translational science. 12 rising sophomores and above will be recruited each summer for a 10-week
long NURE session. We anticipate recruiting students from a variety of undergraduate majors including biology,
chemistry, biochemistry, pre-physical therapy, pre-occupational therapy, pre-pharmacy, neuroscience, physics,
computer science, and biomedical engineering. We aim to include a diverse population of students by recruiting
nationally from large research universities, historically black colleges and universities, Hispanic-serving
institutions, and regionally from low research and primarily undergraduate institutions.

Public health relevance
PROJECT NARRATIVE The Neuroscience Undergraduate Research Experience (NURE) is designed to improve the treatment of all diseases involving neurodegeneration and inclusive of chronic pain. By providing an enriched biomedical research experience combining basic science with professional development, this project will build a new pipeline of students to study and impact the treatment of neurological diseases that have a large and growing public health burden. Students in the program will be recruited from across the country to represent diverse perspectives and broad personal experiences.